Investigating the Impact of Financial Toxicity in Young Adults with T1D

PROJECT SUMMARY
About 1 in 4 Americans who use insulin report rationing their insulin to save money. Emerging adults living with
type 1 diabetes (T1D) have worse glycemic outcomes than other age groups. During this developmental stage,
young people are compelled to navigate healthcare and insurance for the first time independently, while also
experiencing the highest rates of poverty and unemployment among adults. Notably, researchers in the cancer
literature have begun to describe this objective financial burden and subjective financial distress of healthcare
costs, collectively named financial toxicity. In the last 10 years, financial toxicity has been described,
measured, and targeted as the focus of interventions in cancer research. It is timely to elucidate how emerging
adults with T1D experience these financial and healthcare burdens, mirroring the understanding of financial
toxicity in the cancer literature into diabetes research.
Katherine Wentzell, PhD, PNP, BC-ADM is a pediatric nurse practitioner and early-career clinical researcher
who will target this understudied area in T1D in her K23 proposal focused on emerging adults. In her recent
doctoral and postdoctoral work, she developed a new measure of diabetes distress in emerging adults, which
included an item about the worry about diabetes costs and this item was the most highly endorsed on the
survey. This preliminary work underscored her interest in investigating the impact of financial stressors in
emerging adults with T1D, especially those with suboptimal glycemic control. She has assembled a
multidisciplinary mentorship team led by national experts in diabetes clinical and behavioral research, as well
as advisors with focused methodological and cost-related expertise.
This K23 career development proposal includes 3 specific aims incorporating mixed-methods research and
culminating in a pilot randomized controlled trial. In Aim 1a, Dr. Wentzell will use semi-structured interviews to
describe the experience of financial toxicity, health insurance access, and cost-coping behaviors in a diverse
sample of emerging adults. In Aim 1b, she will utilize the innovative methodology of asynchronous online text-
based focus groups to expand the understanding of cost related non-adherence and financial toxicity in
emerging adults with T1D. In Aim 2, Dr. Wentzell will develop and validate a new measure of financial toxicity
and explore relationships among social determinants of health, health insurance access, and psychological
factors as they relate to objective financial burden, subjective financial distress, and glycemic outcomes in a
diverse nationwide sample of emerging adults with T1D. Finally, building on the results in the prior aims, in Aim
3, she will develop, implement, and evaluate a pilot psychoeducational intervention to reduce subjective
financial distress and cost related non-adherence in emerging adults with suboptimal glycemic control.
Through the proposed career development award, Dr. Wentzell will acquire important skills in mixed-methods
and intervention research to reach her goal of becoming an independent clinical investigator.

Public health relevance
PROJECT NARRATIVE While 1 in 4 Americans with diabetes who require insulin therapy ration their insulin to save money, emerging adults with type 1 diabetes report even higher rates of cost related non-adherence and experience worse glycemic outcomes. The goals of this career development project are to understand objective financial burden and subjective financial distress, as well as associations with social determinants of health, cost-coping behaviors, health insurance access, and glycemic outcomes in emerging adults with T1D, leading to the development and pilot testing of a psychoeducational intervention to reduce financial toxicity and cost related non-adherence. This research will advance the understanding of financial toxicity in diabetes and support Dr. Katherine Wentzell on her trajectory towards becoming an independent clinical investigator.